Stretch-Dependent Calcium Signaling in Heart

DESCRIPTION (provided by applicant): Ca2+ sparks in heart have been shown by the PI to occur under physiological conditions during diastole and systole. They not only underlie the normal [Ca2+]i transient but have been found to be critically important in mediating the cellular response to stress and disease, contributing to contractile and arrhythmic dysfunction in conditions ranging from calcium overload to the cardiomyopathy of muscular dystrophy. Recently, work by the PI shows that physiologic stretch, such as that experienced by a myocyte during diastolic filling, dramatically alters Ca2+ spark occurrence transiently in normal cardiac ventricular myocytes. This behavior depends on microtubules affecting the release mechanisms of the sarcoplasmic reticulum (SR). Despite the importance of this new discovery one year ago, we have only now developed the additional tools needed to investigate how dynamic length changes can affect the triggering of Ca2+ sparks under diverse conditions. Using these new tools, we observe (in preliminary investigations) that stretch-dependent changes in Ca2+ sparks are even larger than previously observed and appear to arise from a transient increase in the sensitivity of ryanodine receptors (RyR2s). Additional preliminary work shows that, surprisingly, this transient increase in Ca2+ sparks underlies the activation of arrhythmogenic Ca2+ waves at a very low rate in heart cells from control mice, but at a much higher rate in myocytes from mdx mice, the murine model of Duchenne muscular dystrophy, or from control mice with excessive calcium in the SR. The tools developed by the PI and his colleagues will enable an innovative state-of-the-art investigation into how cardiac Ca2+ signaling is modulated by physiological stretch. The proposed work seeks to investigate stretch-dependent Ca2+ sparks and Ca2+ waves in 1. control ventricular myocytes;2. ventricular myocytes in which RyR2 properties have been altered;3. ventricular myocytes when microtubules are modulated;4. ventricular myocytes from dystrophin null (mdx) mice. The planned research should reveal for the first time the importance of stretch in normal and pathological Ca2+ signaling of cardiac ventricular myocytes. The work will therefore provide not only fundamental new information on normal cellular behavior but also on mechanisms of arrhythmogenesis. Furthermore it will lay the foundation for novel therapies for diverse heart diseases including Duchenne muscular dystrophy. PUBLIC HEALTH RELEVANCE: Contraction and the heart rhythm are regulated by calcium inside of heart cells. This calcium level is now known to be set in part by changes in the cell length (these changes are also called "stretch"), a surprising result that was discovered recently by the scientists working on this proposal. The planned work will examine such stretch-dependent changes in cellular calcium and function and determine how stretch underlies normal and defective heart function.

Public health relevance
Contraction and the heart rhythm are regulated by calcium inside of heart cells. This calcium level is now known to be set in part by changes in the cell length (these changes are also called "stretch"), a surprising result that was discovered recently by the scientists working on this proposal. The planned work will examine such stretch-dependent changes in cellular calcium and function and determine how stretch underlies normal and defective heart function.